Synthesis of Neurologically Active Small Molecules

PROJECT SUMMARY-ABSTRACT
The understanding of normal cognitive function and the development of treatments for neurodegenerative diseases
have been enabled by the study of natural products and their synthetic congeners. The extensive discoveries made in this
realm have been limited primarily to the specific activities of abundantly available natural products or simple derivatives
thereof. The long-term goal of this proposal is to develop laboratory routes to complex molecules that act on proteins
associated with neurological disease.
This proposal outlines approaches to limonoids that act on PTP1B and mitigate neuronal dysfunction. Departing
from conventional strategies using second- and third-row metals, this proposal describes the development of first-row metal
catalyzed transformations to empower laboratory routes to complex molecules that contain heterocycles. This state-of-the-
art approach to multistep synthesis will result in broadly useful chemical transformations for carbon-carbon bond formation,
and highly step-efficient routes to access complex small molecules. Powerful medicinal chemistry approaches will be used
to make deep-seated structural modifications to limonoids, which will be used to interrogate molecular mechanisms of
action.
Novel analogs produced by these routes will be used to evaluate small molecule inhibition of PTP1B, which has
been implicated in neurodegeneration. Through structure activity relationship studies and investigations into the binding
mechanism on a molecular level, the therapeutic potential of PTP1B inhibition to improve neurodegeneration will be readily
investigated.

Public health relevance
PROJECT NARRATIVE The aging population in the United States exacerbates the economic and societal impacts of neurodegenerative disorders, which are among the leading causes of death and disability in the elderly. Novel therapeutic targets need to be investigated to address these illnesses, including improving understanding the molecular mechanisms of their inhibition. This proposal describes the development of first-row transition metal catalyzed transformations to provide laboratory routes to generate structurally diverse complex molecules that are inhibitors of PTP1B, a protein recently implicated in neurodegeneration.